Identifying Optimal Antibiotic Regimens to Treat Urinary Tract Infections During Pregnancy

PROJECT SUMMARY
Urinary tract infections (UTIs) are common in pregnancy and can have serious consequences including
pregnancy loss and preterm birth. Minoritized racial and ethnic groups may have higher rates of UTI in
pregnancy, but prior studies had important limitations. While some evidence suggests there are racial and
ethnic disparities in diagnosis and treatment of other infections, little is known about potential disparities in UTI
treatment in pregnancy. This Diversity Supplement would support Ms. Sandra McAteer, a talented master's
student in Epidemiology at the University of Washington, to conduct relevant research and gain skills and
experience needed for a successful career as a program manager leading interventions to improve the health
of women and children. Ms. McAteer's primary mentor will be Dr. Sascha Dublin of Kaiser Permanente
Washington, Co-Investigator on the Parent R01 grant. Dr. Anjum Hajat of the University of Washington will be
co-mentor, bringing expertise in health disparities research. The Parent R01 aims to generate needed
evidence about the comparative safety and effectiveness of antibiotics in pregnancy by analyzing
administrative claims and electronic health records data. The Specific Aims of the Parent R01 are: 1) to
characterize real-world prescribing patterns, concordance with existing guidelines, and antimicrobial
susceptibility patterns relevant to the outpatient treatment of UTIs in pregnancy; 2) to compare the risk of
treatment failure with commonly-used antibiotic regimens; and 2) to evaluate the comparative safety of these
antibiotic regimens with respect to birth defects and perinatal complications. The Parent R01 does not include
a health equity focus, and specifically, it does not examine whether there are differences in UTI incidence or
treatment or in the prevalence of antimicrobial resistance by race or ethnicity. Specific Aims of the proposed
Diversity Supplement Research are to characterize differences in the incidence and treatment of UTI in
pregnancy by patient race and ethnicity, including differences in choice of antibiotic and concordance of
treatment with clinical guidelines. For an exploratory aim, Ms. McAteer will examine differences in antimicrobial
resistance by race and ethnicity. Ms. McAteer's Career Development and Research Plan will include
coursework, directed readings, participation in seminars and conferences, and conducting research supported
by a multidisciplinary group of mentors. These activities will help her build the scientific and professional skills
for a successful career as a program manager leading interventions to improve the health of women and
children from underrepresented groups. Impact: The proposed Diversity Supplement will augment the Parent
R01 by adding a health equity focus and increasing knowledge about differences in incidence and treatment of
UTIs by race and ethnicity. Results could be used to develop targeted interventions to improve care for UTIs in
pregnancy and ultimately to improve health outcomes for pregnant people and infants.

Public health relevance
NARRATIVE This Diversity Supplement would support Ms. Sandra McAteer, a talented master's degree student in the University of Washington Epidemiology Department, to complete her master's thesis and gain skills and experience needed for a successful career as a program manager overseeing interventions to improve the health of women and children. She will carry out research examining differences between racial and ethnic groups in the incidence and treatment of urinary tract infections during pregnancy, an important topic because such infections can lead to serious adverse outcomes. With support from mentors with expertise in epidemiology, biostatistics, health equity, pharmacoepidemiology, and infectious diseases, she will develop research and professional skills critical for a successful career that will improve the health of women and children from underserved communities.